Assessment and Treatment of Cognitive Functioning Deficits in Veterans with PTSD

CDA Overview: This application proposes a mentored training program supporting Dr. Maya O’Neil’s
development into an independent VA Rehabilitation Research & Development (RR&D) investigator with
expertise in posttraumatic stress disorder (PTSD), cognitive rehabilitation, and behavioral clinical trial methods.
Dr. O’Neil is a licensed psychologist at the Portland VA, Assistant Professor of Psychiatry and Medical
Informatics & Clinical Epidemiology at Oregon Health & Science University (OHSU), and recent K scholar.
Training: Dr. O’Neil will increase expertise in PTSD and cognitive rehabilitation research, enhance skill in the
conduct of behavioral clinical trials, and learn how to use VA resources (e.g., Corporate Data Warehouse,
CDW) to support trials. The training plan integrates formal coursework, content trainings, and mentor guidance.
Mentors: Dr. Daniel Storzbach, Portland VA Director of Neuropsychology, Associate Professor of Psychiatry
and Neurology at OHSU; Dr. Kathleen Carlson, Core Investigator at the RR&D National Center for
Rehabilitative Auditory Research (NCRAR) and Health Services Research & Development (HSR&D) Center of
Innovation (COIN), PI of the Portland Chronic Effects of Neurotrauma study site; Dr. Elizabeth Twamley, VA
rehabilitation researcher, Professor of Psychiatry at UCSD, Director of the Clinical Research Unit of the Center
of Excellence for Stress and Mental Health at the San Diego VA, lead author of Compensatory Cognitive
Training (CCT); and Dr. Nina Sayer, Associate Director of the HSR&D COIN and PI of the Minneapolis VA
EBP4PTSD CREATE, and Associate Professor of Medicine and Psychiatry at University of Minnesota.
Project Background: PTSD is associated with deficits in cognitive functioning including memory, learning,
processing speed, concentration, attention, and executive functioning. Though many Veterans benefit from
evidence-based psychotherapy (EBP) for PTSD, there is little research examining the extent to which cognitive
problems are present before and after EBP and are related to change in PTSD symptoms, quality of life, and
functioning. Dr. O’Neil’s pilot research suggests that many Veterans have cognitive functioning deficits even
after completing EBP for PTSD, though there are no evidence-based treatments for these Veterans. CCT is
improves cognitive functioning in Veterans with brain injury history, but is not yet tested in Veterans with PTSD.
Project Aims: The proposed studies will (1) determine the types and magnitude of cognitive problems and
changes in cognitive functioning following EBP and (2) evaluate feasibility, acceptability, and participant
characteristics, and estimate effect sizes, in a pilot test of CCT for Veterans with PTSD-related cognitive
problems. Data from these studies will form the basis for a RR&D Merit submission testing the effectiveness of
CCT for cognitive problems in Veterans with PTSD in a clinical trial during year 4 of the CDA.
Project Methods: We will recruit Veterans from local VA mental health clinics, using the CDW to identify
potentially eligible Veterans if needed. For Study 1, we will examine cognitive functioning, mental health
symptoms, and quality of life in 150 Veterans before and after EBP for PTSD. In Study 2, we will compare CCT
vs. treatment as usual for 36 Veterans with PTSD-related cognitive functioning deficits. We will calculate rates
of recruitment, retention, and intervention participation. Statistical significance will be examined, though our
focus will be on effect size estimates, score ranges, and variability to plan for a follow-up, fully powered RCT.
Anticipated Impact: PTSD-related cognitive functioning deficits are a significant problem for many Veterans.
CCT is an effective cognitive rehabilitation intervention for Veterans with a history of brain injury, but VA
clinicians need data on its effectiveness for Veterans with PTSD-related cognitive functioning deficits. These
studies will provide the data necessary for a larger scale RCT proposal which will be pursued during the fourth
year of the CDA if results show that CCT is as promising as expected for Veterans with PTSD.

Public health relevance
Approximately half a million Veterans receiving services at the VA have Posttraumatic Stress Disorder (PTSD). PTSD is strongly associated with cognitive functioning deficits in areas of concentration, attention, memory, learning, verbal abilities, processing speed, and multitasking. The proposed research will determine the extent to which cognitive functioning deficits remain even after evidence-based PTSD treatment. Compensatory Cognitive Training (CCT) is an evidence-based intervention for cognitive problems that is effective in other Veteran populations such as those with a history of traumatic brain injury (TBI), but CCT has not yet been tested in Veterans with PTSD who don’t have a history of TBI. We will conduct a pilot randomized controlled trial (RCT) of CCT in Veterans who have been treated for PTSD but continue to have cognitive functioning deficits. We will examine feasibility, acceptability, participant characteristics, and effect size estimates in preparation for a fully-powered RCT of CCT for PTSD-related cognitive functioning deficits.